Large Vessel Occlusion Stroke Triage Strategies

Project Summary / Abstract .
This is a K23 resubmission for Dr. Kevin Keenan, a vascular neurologist and early-career clinical
researcher at the University of California, Davis focused on prehospital diagnostic testing for large vessel
occlusion (LVO) stroke triage. It will provide Dr. Keenan with the mentored training he requires to become an
independent stroke emergency medical services (EMS) researcher, including large EMS dataset management
and analysis, machine learning for classification, prospective study design, emergency research ethics, and
R01 grant writing. Primary Co-Mentor Frank Sharp, MD, is a vascular neurologist with expertise in the
development of stroke diagnostic tests using machine learning and over 35 years of R01-level funding. Primary
Co-Mentor Nishijima, MD, MAS, is an emergency medicine physician with expertise in prehospital neurological
emergency trials and decision analysis. Mentors Xin Liu, PhD, Sandra Taylor, PhD, and Kwan Ng, MD, PhD
will provide further machine learning, biostatistical, and stroke expertise to ensure Dr. Keenan’s success.
Based on recent evidence, Dr. Keenan’s central hypothesis is that combining clinical variables predictive of
LVO stroke such as age, sex, time of onset, vitals, atrial fibrillation, the Glasgow Coma Scale, and glucose with
the Cincinnati Prehospital Stroke Scale (CPSS) neurological examination will improve diagnostic and decision
curve analysis performance compared to existing LVO stroke tests that exclusively rely on the neurological
examination. Using machine learning, he will combine these clinical variables and CPSS into a new test called
CLEAR-LVO (CLinical and Exam bAsed Recognition – LVO). CLEAR-LVO will be compared to CPSS alone,
since CPSS is a widely used stroke screening test that can also identify LVO, and multiple recommended but
not widely adopted LVO tests, such as the Los Angeles Motor Scale (LAMS). This research is significant
because of the urgent need to improve prehospital LVO stroke testing so the correct patients can be triaged to
endovascular stroke centers for time-sensitive treatment. It is innovative because it will use machine learning
methods, large EMS datasets, and a decision curve analysis to guide prehospital stroke triage policies.
Specific Aim 1 will test the hypotheses that CLEAR-LVO will diagnose LVO stroke with a statistically and
clinically significantly higher Youden’s Index (sensitivity + specificity - 1) than CPSS and other LVO scales in a
large EMS dataset (n = 86,396). External validation via the Aim 2 dataset will enhance the rigor of our findings.
Specific Aim 2 will test the hypothesis that CLEAR-LVO will provide higher decision curve analysis net
benefit than prospectively documented LAMS and CPSS scores in a separate Yolo County dataset (n = 2,310).
The urgent need to determine whether EMS agencies should use CPSS or LAMS now, while awaiting better
tests, will ensure that Aim 2 and Dr. Keenan’s R01 plans are not dependent on CLEAR-LVO. This K23 will lead
to a multi-center R01 prospectively comparing CPSS, LAMS, and CLEAR-LVO in ambulances, prospective re-
derivation of CLEAR-LVO if indicated, and subsequent triage studies aimed at improving stroke outcomes.

Public health relevance
Project Narrative . The proposed research is relevant to public health because time-sensitive treatment for large vessel occlusion (LVO) stroke is only available at specialized endovascular stroke centers, but the tests available to detect it before choosing which hospital to go to have many shortcomings. The proposed research will determine if a new LVO stroke test that uses machine learning to combine information like age, vital signs, and other factors with the neurological examination will detect LVO stroke better than existing tests that use neurological examinations alone. Our research is relevant to the NINDS’s mission of reducing the burden of neurological disease because it will determine the best test for emergency medical services providers to use to ensure more patients receive faster treatment for LVO stroke and inform future studies aimed at improving stroke triage and patient outcomes.